Mechanisms of Urothelial Metaplasia and Tumorigenesis

DESCRIPTION (provided by applicant): The overall research goal of this proposal is to determine the contribution of specific genetic events to urothelial squamous metaplasia and bladder tumorigenesis, while developing my technical and professional abilities to become an independent investigator. My professional objective is to acquire a position as an Assistant Professor at a superb academic institution that will enable me to perform cutting edge research on molecular mechanisms responsible for bladder tumorigenesis and bladder cancer progression. In addition, I will continue fostering strong interdisciplinary relationships with urologic surgeons and medical oncologists in an effort to leverage my discoveries to address the most pressing clinical and translational research objectives in bladder cancer research. To achieve these goals, I will engage in research training objectives during the mentored K99 phase of this application. Training activities will include attendance of instructional courses in biostatistical analysis methods and clinical trial design. In addition, I will capitalize on the strengths of Department of Urologic Surgery at VUMC by integrating research training with components of the Urologic Oncology Fellowship program, enabling me to attend multidisciplinary urologic oncology meetings, therefore increasing my exposure to the current state of the art in bladder cancer treatment. Additional career development mechanisms will include instructive seminars at national meetings, mentored guidance in grant and manuscript preparation, and academic job interviewing. In addition, an advisory committee will evaluate the completion of both my scientific and career development milestones and facilitate my transition to an independent investigator. Development of squamous metaplasia and subsequently bladder cancer poses a significant risk to health. Moreover, clinical management of bladder cancer is extraordinarily expensive, and imposes a major fiscal burden in health care expenditure. As the molecular mechanisms resulting in squamous metaplasia and/or bladder tumorigenesis are not completely understood, an increased effort is needed to identify novel molecular targets for the management of this common urologic malignancy. Based on our preliminary studies, I hypothesize that PPARγ-mediated FOXA1 expression maintains normal urothelial differentiation, and combined loss of FOXA1 and PTEN promotes squamous metaplasia and bladder cancer tumor progression in an Akt and/or MAPK dependent manner. The specific aims of this study are as follows: Aim 1: To determine the extent in which PPARγ and FOXA1 loss cooperate with PTEN inactivation to promote PI3K/Akt and MAPK pathway activity in vitro and promote squamous metaplasia and tumor progression in vivo. Aim 2: To determine the extent to which FOXA1 KO cooperates with PTEN deletion to drive squamous metaplasia and urothelial tumorigenesis.

Public health relevance
The mechanisms responsible for development of keratinizing squamous metaplasia, and subsequently, squamous cell carcinoma of the bladder remain largely unknown. It is anticipated that the results of this proposal will determine the impact of individual and combined genetic inactivation of FOXA1, PPARγ, and PTEN on these processes. Successful completion of this proposal will identify potential therapeutic targets in patients with FOXA1 and/or PTEN negative bladder cancer, and establish a potential benefit for restoring FOXA1 expression in bladder cancer patients. The written critiques of individual reviewers are provided in essentially unedited form in this section. Please note that these critiques and criteria scores were prepared prior to the meeting and may not have been revised subsequent to any discussions at the review meeting. The "Resume and Summary of Discussion" section above summarizes the final opinions of the committee.